Sex Differences in Pain Reports and Brain Activation in Older Adults with Alzheimers Disease

Project Summary/Abstract Not applicable for supplement application

Public health relevance
Narrative Not applicable for supplement application